IGF::OT::IGF - PRODUCTION ASSISTANCE FOR CELLULAR THERAPIES (PACT)- CELL PROCESSING FACILITIES CELL MANUFACTURING AND PROCESS DEVELOPMENT SERVICES FOR RSA PCT0005-02: CRYOPRESERVATION TECHNICAL STUDY

not provided in contract proposal